High-Precision Non-Contact Plasmon-Induced Intracellular Delivery

ABSTRACT
This research supplement aims to enhance the career development a post-baccalaureate researcher from
underrepresented backgrounds in the PI’s group. At the same time, the supplementary research activity is
designed to provide complimentary data to the parental research activities, and therefore, to build a foundation
on common and translatable biomedical laboratory skills for the trainee. Specifically, we will focus on basic
techniques such as sterilization, cell culture, cell fixing and staining, and optical and electron microscopies with
more advanced instrumentation that are relevant to the day-to-day research activities in cell biology. These highly
transferable skills will benefit the trainee’s career as a future physician, scientist, or both. The career development
plan will include a close mentorship from the PI, in-person training on Responsible Conduct in Research (RCR),
and networking from research collaborations and regional and national seminars, workshops, and conferences.
Ultimately, the research and soft skills developed in this proposed supplement will be a cornerstone for the
trainee’s future career in biomedical-related occupations and therefore contribute to a more diverse and inclusive
biomedical community.

Public health relevance
Project Narrative This research supplement will create a research protocol dedicated to human T-Cell imaging with nanoscale resolution. The outcome would provide insights into fundamental process of human immune system.